Using mHealth to investigate intersectionality and health behaviors: Implications for conceptual models and cancer prevention interventions for marginalized populations

PROJECT SUMMARY/ABSTRACT
Tobacco is the leading cause of preventable death and disease and is linked to approximately 20 cancers.
The rate of decline of tobacco use has been lower for marginalized populations compared to more privileged
groups. Most research on tobacco inequities has examined differences based on a single attribute like
race/ethnicity, yet this ignores heterogeneity within groups and how multiple aspects of a person’s identity like
their race/ethnicity, socioeconomic status (SES), or gender may interact to shape lived experiences and health
behaviors. Intersectionality posits that interconnections among multiple aspects of identity and their
interaction with social, and contextual factors can contribute to inequities. This framework is useful for shifting
focus from broad sectors of the population to groups with disproportionate health risk. Mobile health
methodology (mHealth), such as AutoSense and ecological momentary assessment (EMA), provide real-time
objective and subjective assessments of how and when emotions and behaviors change depending on time and
context and can inform just-in-time adaptive interventions for populations disproportionately affected by
tobacco use. The objective of this proposal is to advance methodological and content knowledge of the utility
of intersectionality for examining psychosocial, behavioral, and contextual factors that contribute to tobacco
use and cancer inequities. Training goals incorporate tobacco use and health inequities, mHealth
methodology, advanced statistics, and professional development.
The K99 phase will take place at the Huntsman Cancer Institute and focuses on tobacco use and
mechanisms of behavior change (e.g., stress, affect, self-efficacy) in intersectional groups using the existing
EMA and AutoSense data of the primary mentor, Dr. David Wetter, who is an expert in mHealth, health
inequities, and interventions targeting tobacco behavior change. Training with co-mentors Benjamin Haaland
in advanced statistics, Dr. Inbal ‘Billie’ Nahum-Shani in behavioral theory and the development of adaptive
interventions, and Dr. Nicole Else-Quest in quantitative intersectionality research will contribute to training
goals. The R00 phase will consist of a novel intersectionality study using AutoSense and EMA to investigate
the real-time dynamics of intersectional identities with stress, negative affect, self-efficacy, and tobacco use in
real-time. This work is innovative because no studies to-date have examined tobacco use inequities using an
intersectionality framework, nor have any studies combined this framework with the use of cutting-edge
technology like AutoSense and EMA to investigate tobacco use inequities in real-time. This work can directly
inform tailored interventions targeting tobacco use behaviors among populations at specific sociodemographic
intersections that confer inequitable cancer risk and directly addresses the NCI’s mission to conduct and
support cancer research to advance scientific knowledge and help all people live longer, healthier lives.

Public health relevance
PROJECT NARRATIVE Tobacco use is the leading cause of preventable death and disease in the US and is linked to nearly 20 different cancers . Although overall rates of tobaccouse have declined, the rate of decline has been much lower among marginalized groups who may experience greater exposure to certain social and contextual stressors (e.g., discrimination) that may impede health behavior change. This research will use a novel methodological and conceptual approach called intersectionality and cutting-edge mobile health technology (i.e., ecological momentary assessment and AutoSense) to examine how multiple aspects of sociodemographic identity, context, and interpersonal experiences interact to shape health inequities, which will improve the identification of specific populations at disproportionate risk for tobacco and cancer inequities and can inform the development of targeted cancer prevention interventions.